Discovery of novel regulatory territories in the TNF/LT locus

Our goal is to understand the mechanisms of cell type- and stimulus-specific regulation of the
human TNF gene and the TNF/LT locus genes (LTA and LTB) in T cells and monocytes/macrophages and
to identify genomic regions that could potentially be targeted in TNF-driven disease states. Using unbiased
next generation sequencing (NGS) approaches and CRISPR editing of human cells and mice, we will
identify and elucidate function of transcriptional regulatory elements that modulate TNF, LTA, and LTB gene
expression in T cells and monocytes/macrophages during activation and differentiation conditions and
infectious challenges. Our preliminary studies using the NGS approaches of stranded RNA-, ATAC-, and
HINT-seq reveal multiple novel highly conserved non-coding elements that transcribe eRNA in a cell type-
specific manner in naïve T cells and in human monocytes/macrophages. They also show the cell type-
specific hHS-8 enhancer that controls IFN-γ priming in monocytes/macrophages and enhances TNF and
LTA in activated T cells we previously described. Our first goal will be to define the transcriptional territories
and potential intrachromosomal interactions between the novel elements and hHS-8 with the TNF, LTA, and
LTB genes. We will use ChIP-seq to determine the recruitment of the architectural protein CTCF, which
mediates chromatin conformation, and the enrichment of H3K27Ac and H3K24Me, which are associated
with enhancers. To select high potential regulatory areas this data will also be evaluated by a phylogenetic
analysis of the TNF/LT locus in non-human primates to define highly conserved regions that predict
regulatory function. These studies will guide our 3-dimensional analysis of locus architecture with Hi-C and
CRISPR deletion of potential regulatory elements in cell lines and primary cells to establish their function.
These studies then will provide a powerful framework and data set from which to interrogate these sites and
new regulatory elements we will uncover in our analyses of (i) different states of human T cell and
macrophage differentiation stimulated with TCR ligands or LPS and/or IFN-γ, respectively; (ii) the TNF/LT
locus in primary T cells and BMDM from C57BL/6 and Balb/c mouse strains to evaluate concordance
between the regulation of the murine and human TNF/LT loci as a baseline for performing studies in
CRISPR-edited mice and testing the role of elements in acute (sepsis) and chronic (arthritis) TNF-mediated
disease models. We will also characterize the role of distal elements that regulate TNF and the IL-6 gene
expression, which shares regulatory similarities with TNF during infection with M. tuberculosis (MTb) or
RNA viruses (Sendai and SARS-CoV-2), to elucidate broader gene expression programs. We anticipate
that these studies will lead to a new understanding of how the TNF/LT genes are coordinately regulated,
provide fundamental insights into gene regulation and the role of distal elements, and provide potential
genomic targets to regulate TNF in a cell type-and inducer-specific manner in disease states.

Public health relevance
TNF (tumor necrosis factor) is a critical innate immune response gene that has a profound impact on a number of autoimmune and infectious diseases outcomes. We have discovered long-range regulatory elements, which control expression of TNF in a cell-type specific manner. Understanding how these elements control TNF gene expression will provide fundamental knowledge about the regulation of TNF and potentially other genes and we expect will lead to novel and specific therapeutic strategies for autoimmune and infectious disease where TNF causes immune pathology.